Biomolecular Interactions and Enzymatic Processes

Program Director/Principal Investigator (Last, First, Middle): Gao, Jiali
Project Summary
A multi-faceted research project is directed aimed at computational studies of photochemically induced
processes and interactions in photoreceptor proteins. The theoretical approach centers on molecular dynamics
and nonadiabatic quantum dynamics simulations of the ultrafast excited energy transfer and charge transfer as
well as the subsequent protein conformation change that triggers signal transduction. We employ multiscale
simulation techniques, including combined quantum mechanical and molecular mechanical (QM/MM) methods
to describe intermolecular interactions. A major goal is to increase the capability of QM/MM methods to model
photochemical processes and to achieve greater accuracy than conventional approaches. We propose to
develop multistate density functional theory (MSDFT) to define excitation, charge, and spin localized states.
We also plan on further explore the computationally efficient multistate tight-binding density functional theory
(MS-DFTB) to perform long-time dynamics simulations. The MSDFT method follows a dynamic-then-static
ansatz, in which dynamic correlation is incorporated into the basis states in the first place. As such, the basis
configurations in the active space are highly contracted, which significantly reduce the number of
configurations needed and the computational costs. Yet, MSDFT is also accurate. Applying the
MSDFT/CHARMM combination, we aim to understand the nature of the photochemical and photophysical
processes following light absorption in cryptochromes. In addition, we aim to understand the light harvesting
mechanism of the ultraviolet-B receptor UVR8, and its light-induced dimer photodissociation process. A long-
term goal is to understand the nature of protein-protein interactions between UVR8 and homologous proteins.
PHS 398/2590 (Rev. 06/09) Page Continuation Format Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Gao, Jiali Project Narrative Signal photoreceptors play essential roles in all kingdoms of life. It might be hard to imagine there is anything in common in phototropism of plants, jet lag of traveling, and bird migration across continents. Yet, they are all modulated by light absorption associated with cryptochromes. An understanding of light-signal propagation to trigger biological activities at the molecular level can help design and engineer novel fluorescent proteins, biosensors, and optogenetic tools for imaging, detecting and controlling biological processes by light. PHS 398/2590 (Rev. 06/09) Page Continuation Format Page